Pathophysiology of Chronic and Delayed Mustard Gas Keratopathy

Abstract
This is an application to the Countermeasures Against Chemical Threats (CounterACT) NIH-wide program part
of the Chemical Countermeasures Research Program. Sulfur mustard (SM), a chemical warfare agent, and
nitrogen mustard (NM), a chemotherapeutic agent, are both potent vesicants. The cornea is exquisitely sensitive
to these agents leading to keratitis, vascularization, ulceration, and perforations. Following acute SM exposure,
a subset of patients will experience chronic/delayed-onset ocular complications known as mustard gas
keratopathy (MGK). Delayed MGK reportedly can manifest several years after the initial exposure and presents
with severe corneal disease with significant visual loss. We have made the observation that in experimental
animal models of NM injury to the cornea, there is dose-dependent increased senescence in the cornea. We
hypothesize that senescence in the cornea promotes tissue dysfunction and inflammationand that senescence
after mustard injury contributes to the progression of chronic MGK and the severity of delayed MGK. We
further hypothesize that reducing/eliminating senescent cells may alter the progression and severity of MGK. In
this application we propose in Aim1 to investigate the role of senescence and SASP in the progression of
corneal disease following acute exposure to NM; and in Aim 2 to investigate the role of senescence in a new
model of delayed MGK. At the conclusion of these studies, we expect to have an improved understanding of the
role of senescence in the development of MGK and identify novel approaches for its prevention/treatment.

Public health relevance
Project Narrative Eye injuries from exposure to the chemical warfare agent sulfur mustard can lead to severe blinding diseases. In response to NIH Chemical Countermeasures Research Program, we are proposing to to investigate the role of senescence after such injuries and to identify pathways for preventing/treating the severe blinding complications.